Visualizing insulin actions on neuronal metabolism and function using fluorescent biosensors

ABSTRACT
Reduced glucose utilization and energy production in peripheral tissues are major issues contributing to
decreases in healthspan with age and represent a major challenge for the healthcare system. Although insulin
actions and resistance have been extensively studied in peripheral tissues, the precise role of insulin in brain
energy dynamics and brain health remains an enigma. Despite the well-accepted importance of glucose for
normal brain function, direct glucose utilization by neurons and its effect on aging and age-related diseases have
been highly controversial. Contrary to the popular ‘astrocyte-to-neuron lactate shuttle hypothesis’, we reported
that neurons are a site for aerobic glycolysis, revealed by transient elevations in the cytosolic NADH/NAD+ ratio
(measured with the genetically encoded fluorescence lifetime biosensor, Peredox). In addition, these metabolic
responses increased after inhibiting both astrocytic and neuronal monocarboxylate transporters (MCT), which
prevented lactate transfer from astrocytes to neurons. The mechanisms contributing to the mismatch between
glucose consumption and oxygen utilization in neurons are not understood and are the focus of this application.
These fundamental questions must be resolved before we can advance our understanding of the effects of
metabolic diseases and aging on the brain. Thus, the premise of this application is that insulin action at the
neuronal level has a key role in regulating glucose supply and oxygen utilization. The overarching goal of my
laboratory is to elucidate the regulation of energy metabolism in the brain with age, and this proposal uses adult
animals to rigorously define the role of insulin on neuronal metabolism. Using genetically encoded fluorescent
biosensors and 2-photon fluorescence lifetime microscopy, we will detect simultaneous readouts of neuronal
excitability and metabolism in brain slices. This model preserves the complex 3D organization and circuitry of
native brain tissue. Specifically, we hypothesize that glycolysis and oxidative phosphorylation in neurons are
directly regulated by insulin signaling, which increases energy metabolism (ATP synthesis), the restoration of
cytosolic calcium levels, and synaptic plasticity. In this application, we will focus on the dentate granule cells
(DGC) of the mouse hippocampus, a structure required for learning and memory and shows high insulin receptor
(IR) expression and phosphorylation. It is also known that insulin can cross-react with the IGF-1 receptor (IGF-
1R), although with less affinity, and that double knockout mice for these receptors in the hippocampus manifest
as disrupted spatial learning and memory. However, the individual contribution to cognition of the signaling
through each receptor has yet to be determined. The following aims are proposed: Aim 1: Define the mechanisms
of insulin signaling on energy metabolism in neurons. Aim 2: Characterize the role of neuronal insulin signaling
on cytosolic calcium dynamics and synaptic plasticity in the hippocampus. Aim 3: Investigate the role of neuronal
insulin resistance on learning and memory. Our results have the potential to resolve the association between
aging, metabolic diseases, and cognitive decline and provide a route to new therapeutic interventions.